Novel tetrahedron beam CT for point-of-care imaging in ear, nose and throat imaging

ABSTRACT
Point-of-care imaging is highly desired in otolaryngologic clinics for the diagnosis of ear, nose and throat
(ENT) diseases including cancers. Due to limited image quality, current cone-beam CT (CBCT) products act
not as a substitute but rather as a complement to diagnostic Multi-slice CT (MSCT) in maxillofacial and ENT
imaging. The emerging multi-source x-ray source technology suggests new designs of CT systems that may
have faster imaging speed, improved image quality, reduced radiation exposure, and compact geometries.
Tetrahedron Beam Computed Tomography (TBCT) is a compact volumetric CT based on linear array multi-
pixel x-ray sources which can produce diagnostic-quality volumetric images but in a much more compact
geometry than CBCT. During Phase I study, we successfully developed a benchtop ENT-TBCT system
using a multi-pixel thermionic emission x-ray (MPTEX) source developed in-house and a state-of-art
commercial photon-counting detector (PCD), and demonstrated the superior image quality that TBCT can
achieve. During the Phase II study, we will further refine the MPTEX source and develop a clinical
prototype system. To achieve this goal, we propose to perform studies to achieve the following Specific
Aims (SA): SA 1: To develop a rotatable sealed MPTEX source; SA 2: To develop a clinical ENT-TBCT
prototype on a rotating gantry; and SA 3: To develop advanced image reconstruction algorithm and perform
benchmark imaging studies. The outcome of this research will be a highly effective point-of-care diagnostic
imaging modality for otolaryngologic clinics. Future commercialization of the ENT-TBCT system will improve
the quality and efficacy by supporting prompt diagnosis and treatment of ENT cancers and other diseases.

Public health relevance
NARRATIVE CT is an indispensable, first-line diagnostic imaging modality for cancers and other diseases in ear-nose- and-throat (ENT) clinics. Point-of-care imaging is crucially important in ENT clinics. During the last decade, enabled by x-ray flat-panel imager technology, cone-beam CT (CBCT) has become an important imaging modality for image-guided radiotherapy and intervention. Although several vendors have developed CBCT for ENT point-of-care imaging, the clinical usefulness of CBCT, however, is very limited due to its inferior image quality, making CBCT incompetent in the diagnosis of soft tissue diseases. In this project, we will develop a novel Tetrahedron Beam Computed Tomography (TBCT) system based on multi-pixel x-ray source technology. Unlike current CBCT that employs wider detectors to increase axial coverage, TBCT revolutionarily employs a linear x-ray source array to achieve the same coverage, thus fundamentally eliminates the inherent problems of CBCT. In this project, we will develop and commercialize the novel ENT-TBCT system for point-of-care imaging in ENT clinics. It is expected to produce superior high image quality and reduce low x-ray exposure to the patients, significantly improve the efficacy and quality of ENT clinics.